S-ADENOSYLMETHIONINE AND AFFECTIVE DISORDERS

S-Adenosyl-L-methionine (AdoMet) is a safe and probably effective antidepressant agent in certain forms of clinical depression. A new hypothesis is offered to account for the mechanism of action of S- adenosylmethionine in such illness, based upon the known biochemistry of this compound, and upon current knowledge of clinical and genetic aspects of affective disorders. We postulate that at least some major mood disorders are due to abnormalities affecting the AdoMet dependent methylation of a substance in the central nervous system. For convenience and without prejudging the chemical structure of this substance, we term it for the moment "barinine". The model requires that barinine be subject to AdoMet-dependent methylation and that methylbarinine be subject to metabolic demethylation to regenerate the original barinine. Methylbarinine should be mood elevating, whereas barinine itself should not be. Depression is a result of methylbarinine, while mania results from an abnormal elevation of methylbarinine.